Targeting the Mesocortical Glutamatergic Pathway for Chronic Pain Treatment

Project Summary
The malfunction of the mesocortical pathway, connecting the ventral tegmental area (VTA) to the prefrontal
cortex (PFC), has been associated with nerve injury-induced neuropathic pain. While extensive research has
focused on dopamine transmission in reward and aversion within this pathway, the specific role of glutamate
signaling in pain modulation remains largely unknown. Previous studies from our lab and others have
demonstrated that pyramidal neuronal activity is substantially reduced in the mouse PFC after peripheral nerve
injury, and restoring PFC activity alleviates neuropathic pain. Our recent work suggests that optogenetic
stimulation of VTA glutamatergic projections in the PFC alleviates nociceptive allodynia and pain aversion. Based
on these findings, we hypothesize that the VTA-to-PFC glutamatergic pathway plays a crucial role in the
development and maintenance of chronic neuropathic pain. In this application, we will test this hypothesis by
combining in vivo imaging of calcium activity, VTA cell type- and projection-specific chemogenetics, and the
CRISPR/Cas9 gene editing approach. The proposal has two specific aims. In the first aim, we will examine the
alterations in VTA glutamatergic inputs to the PFC after peripheral nerve injury and their contribution to the
development of chronic pain. This will test whether reduced VTA glutamatergic inputs deactivate the PFC, thus
contributing to pain chronicity. Additionally, previous studies have shown that a fraction of VTA glutamatergic
neurons co-release dopamine. In the second aim, we will employ CRISPR/Cas9 gene editing to selectively
deplete tyrosine hydroxylase, an enzyme involved in dopamine biosynthesis, to determine whether activating
the VTA-to-PFC glutamatergic pathway reverses established neuropathic pain independently of dopamine co-
release. The proposed project will determine the pivotal role of a non-conventional mesocortical glutamatergic
pathway in the development and maintenance of neuropathic pain. The successful completion of the project will
provide novel insights into targeting the VTA-to-PFC glutamate signaling as a therapeutic strategy for chronic
pain treatment.

Public health relevance
Project Narrative Neuropathic pain affects millions of people and is difficult to treat. This project investigates projection- and cell- type-specific changes in pain circuits during the development and maintenance of chronic pain after peripheral nerve injury in animal models. The findings will provide important insights into the role of the mesocortical glutamatergic pathway in neuropathic pain and identify potential therapeutic targets.